Progression of Dysphagia in Parkinson's Disease

PROJECT SUMMARY/ABSTRACT
Parkinson’s disease (PD) is a progressive, neurodegenerative condition that impacts multiple sensorimotor
systems. Swallowing disorders (dysphagia) occur frequently in PD and can devastatingly impact morbidity,
mortality, and quality of life. As PD-centered medical and surgical approaches do not meaningfully impact
dysphagia, behavioral rehabilitation is the standard of care for persons with PD-related dysphagia. However, it
is unknown when and how swallowing function begins to decline in PD, prior to crossing the threshold into
clinical dysphagia. This unclear understanding of dysphagia progression in PD leaves a critical gap in
knowledge, forcing clinicians to wait to begin therapy until the patient complains of dysphagia, which may not
occur until a point when significant neurodegeneration has occurred and lasting improvement in swallowing
function may be unattainable. Several quantitative, objective, and sensitive techniques for measuring
swallowing physiology have identified differences in function between healthy individuals and those with PD,
but it is unknown how these measures of physiology change over time. In this study, we aim to identify
measures that characterize progression of swallowing dysfunction in persons with Parkinson’s disease. This
study proposes a cross-sequential, observational design to comprehensively assess swallowing physiology in
a cross-sectional and longitudinal manner, paving the way for improved understanding of swallowing decline in
PD and for a personalized medicine approach for dysphagia rehabilitation. Specifically, this study will allow for
the collection of sufficient preliminary data and optimization of data collection and analysis protocols to support
an NIH R01 application, with the overall objective to longitudinally follow patients, asses for dysphagia
progression, and develop algorithms to predict risk for dysphagia development. Our central hypotheses are
that 1) Pressure and mastication measures will exhibit greater amounts of change over time than imaging or
respiratory measures; and 2) Rate of swallowing function change will be slower in early-stage PD compared to
mid-stage PD. Optimization of comprehensive swallowing physiology assessment will lead to improvements in
understanding of progression of swallowing deficits and potential for behavioral modification of swallowing in
persons with PD. Improved characterization of swallowing decline will lead to more precise assessment and
diagnosis of dysphagia, better targeting of windows of opportunity for swallowing rehabilitation, and more
specific outcome measurements as the field explores novel treatment approaches.

Public health relevance
PROJECT NARRATIVE Parkinson’s disease can devastatingly impact swallowing function, resulting in dysphagia. The progression of dysphagia in persons with Parkinson’s disease is largely unknown, which limits the medical team’s ability to intervene in a critical rehabilitation window for optimal swallowing outcomes. In this study, we will collect preliminary longitudinal swallowing data in individuals with early- and mid-stage Parkinson’s disease in preparation for a large-scale longitudinal study of decline of swallowing function to better understand dysphagia progression, optimal rehabilitation windows and strategies, and relevant outcome measures.